South Dakota Pediatric Clinical Trials Network (SoDakPCTN)

PROJECT SUMMARY
This proposal seeks to con�nue to build pediatric clinical trials capacity in South Dakota through the South Dakota
Pediatric Clinical Trials Network. The Avera Health system and partners are ideally suited to conduct pediatric clinical
trials that speciﬁcally reach rural, fron�er, and American Indian popula�ons in South Dakota. Due to vast distance and
lack of qualiﬁed providers, rural popula�ons, especially children, face signiﬁcant barriers to access to quality care and
research opportuni�es. Even with these challenges, the SoDakPCTN team has consistently engaged rural popula�ons and
clinic partners to ﬁnd crea�ve solu�ons to implement clinical trials in community-based se�ngs. We will build on our
exis�ng collabora�ons to grow pediatric research across hospital and community se�ngs in South Dakota.
This project has three aims: (1) Develop, conduct, and disseminate ﬁndings from mul�center clinical trials research. (2)
Build clinical trial capacity at the clinical site and (3) Engage interested community members, non-proﬁt organiza�ons,
and professional socie�es to enhance ECHO ISPCTN clinical trial impact, transferability, rigor, and feasibility.

Public health relevance
SoDAkPCTN PROJECT NARRATIVE The South Dakota Pediatric Clinical Trials Network will build pediatric clinical trials capacity in South Dakota to improve clinical trial access to rural children. Given the high level of health dispari�es in our region, par�cularly amongst the American Indian (AI) popula�ons, coupled with the remote nature of our rural communi�es, a mechanism for the development of pediatric clinical trials research will be cri�cal to the health of children in our region.